Mechanisms associated with systemic effects of cancer

Problems noted: Functional limitation, sarcopenia, sarcopenic obesity, and cachexia in the metastatic setting
are common across many cancers. Functional limitation is mechanistically concomitant to the paracrine effects
of cancer and is likely due to skeletal muscle dysfunction including aberrant stem-progenitor-differentiated cell
myogenesis hierarchy. Although cachexia is rare in breast cancer, cancer- and/or treatment-induced skeletal
muscle dysfunction and sarcopenia are common in breast cancer patients. However, it is unknown whether
tumor subtypes with distinct genomic aberrations, and consequently different paracrine signaling features,
differentially affect the myogenesis hierarchy. It is also unknown whether cancer-induced skeletal muscle
defects are gender-specific, and, if so, how gender-enriched hormones influence myogenesis.
Relevant findings from the current funding: Mammary tumors in MMTV-PyMT mice, a model for luminal B
breast cancer subtype, had distinct effect on skeletal muscle compared to mammary tumors in MMTV-Neu
mice. Compared to control animals, both models demonstrated reduced expression of skeletal muscle stem
cell (MuSC)-associated transcription factor Hoxa9, reduced levels of myogenic microRNA miR-486 in
circulation and in skeletal muscle, increased extracellular matrix deposition, and lower grip strength and
rotarod performance. However, only the MMTV-PyMT model demonstrated reduced expression of Pax7,
another MuSC transcription factor, and mitochondrial dysfunction. By contrast, only the MMTV-Neu's skeletal
muscle phenotype resembled that of Duchenne muscular dystrophy (DMD) models. Furthermore, as with DMD
models, skeletal muscle defects in MMTV-Neu could be rectified through muscle-specific overexpression of
miR-486. These differences in skeletal muscle phenotype correlated with differences in circulating cytokine
profiles between the two models.
To further develop circulating miR-486 as a biomarker of cancer-associated skeletal muscle defects, we
analyzed plasma samples of bladder, lung and pancreatic cancer patients. Intriguingly, striking reduction of
circulating miR-486 in men but not women was observed in these cancers. In vitro studies showed that
estradiol (E2) or toremifene, a clinically used selective estrogen receptor modulator (SERM), increased miR-
486 in myogenic cell lines and both E2 and toremifene reduced the levels of smad2, a miR-486 target. Smad2
is an integral part of myostatin/activin A/B-induced signaling that mediates muscle loss in cancer. Thus, E2 or
SERMs can potentially be used to reduce skeletal muscle defect and improve quality of life for men with
various cancers. Additionally, discontinuation of anti-estrogen aromatase inhibitor therapy by breast cancer
patients secondary to treatment-induced muscle weakness could be due to impaired E2-mR-486 signaling.
Hypothesis: Breast cancer patients experience DMD-like skeletal muscle phenotype depending on genomic
aberrations in cancer, and gender also has an effect on muscle function in other solid tumors. Therefore,
integrating cancer genomics with gender is required to understand skeletal muscle biology in cancer.
Aims: 1) To demonstrate that genomic aberrations in cancer determine the types of molecular defects in
skeletal muscle, 2) To establish that gender specific differences in circulating and skeletal muscle levels of
miR-486 exist across solid tumors 3) To investigate whether aromatase inhibitors alter myogenic transcription
factor network through deregulation of E2-regulated microRNAs including miR-486, and 4) To determine the
effects of E2 or toremifene in reducing functional limitations in male cancer models.
Study impact: This study will develop an individualized method to assess the effect of cancer on skeletal
muscle, similar to current efforts of characterizing tumors at the individual level. If E2 or toremifene proves to
be effective in reducing cancer-induced systemic effects in male models of cancer by disrupting myostatin-
smad2/3 signaling, they can be translated immediately into clinic as both drugs are already in clinical use.

Public health relevance
The proposed studies will determine whether genomic changes in cancer as well as the gender of a patient determine the type of molecular defects that occur in skeletal muscle. We will develop a model system to identify skeletal muscle defects at an individual patient level and will investigate whether estradiol or clinically used toremifene can reduce cancer-induced defects in muscle in males. Positive outcomes from the study can be immediately translated into clinic.